Polymeric Micelles for Targeted Delivery of Contrast Agents Through the Nose-to-Brain Route in Image-Guided Brain Cancer Surgery

Surgery has a key role in the management of many types of brain cancers. In fact, the completion of surgical
resection is a key prognostic factor in brain cancer treatment. This requires surgeons to identify residual
tumors as well as to margin the proximity of the tumor to adjacent normal tissue. Subjective assessments, such
as palpation or visual observations, are commonly used by oncology surgeons during resection to differentiate
cancer lesions from normal tissue, which could potentially result in either an incomplete tumor resection, or
accidental removal of normal tissue. Moreover, malignant brain tumors are even more difficult to distinguish
from normal brain tissue, and resecting noncancerous tissue may create neurological defects after surgery.
Therefore, utilizing an intraoperative, real-time guidance technique in the operating room is essential to quickly
optimize the resection margin in brain tumors ultimately improving surgical outcomes. In this proposed study,
first, we aspire to develop and characterize tumor-targeting polymeric micelles that carry a self-quenched near-
infrared (NIR) imaging agent (Aim 1). These will be a micelles-based on/off fluorescence switch system where
the whole-body fluorescence remains low (“off”) until those are released from the micelles as monomers,
emitting strong fluorescence (“on”) on the tumor tissues. Secondly, we will evaluate the practicality of this
system when administered intranasally for providing optical image guidance during brain cancer surgery. In
vivo whole-body optical imaging on glioma-bearing xenograft mice will be obtained upon intranasal delivery of
the tumor-targeting polymeric micelles carrying an NIR imaging agent in self-quenched state (Aim 2A). We will
then test this system in the “simulated” operating room where intranasally delivered system provides
intraoperative image guidance to support complete tumor excision and superior surgical outcome on glioma-
bearing xenograft mice (Aim 2B). We believe that intranasally administered polymeric micelles developed for
this proposed work will help overcome some fundamental challenges that fluorescence imaging faces by
avoiding the BBB and delivering a contrast agent effectively and selectively to brain tumors.
We expect that the results we obtain from this proposed work will open the possibility of employing intranasally
administered optical imaging agent for visualizing brain tumors that minimizes incomplete tumor resection or
accidental removal of surrounding normal tissues during surgery. Tumor removal surgery supported by
intraoperative image guidance will highly likely demonstrate high surgical accuracy and precision and can
significantly improve surgical outcomes and patient survival, potentially adding decades of quality life.

Public health relevance
The removal of a tumor is an important stage of treatment, as it allows the extraction of a large volume of tumor tissue, the reduction of intracranial pressure, the decrease of neurological deficit and the establishment of an exact tumor phenotype to solve the question of further treatment tactics. Modern research has shown that the size of tumor resection is reliably correlated with the life expectancy of patients. In the case of diffuse astrocytomas with a low degree of malignancy, total tumor removal is a key prognostic factor as it effectively reduces the risk of malignant tumor transformation. For adult patients with brainstem high-grade gliomas, one of the rarest and deadliest forms of brain cancer, surgically removing the entire tumor may add many months or potentially years of survival beyond that offered by radiation and chemotherapy. The main paradigm of brain tumor surgery is the maximal removal of the tumor with minimal risk of damage to functionally significant areas of the brain. However, the extraction of a tumor in the white light of a microscope can only achieve a maximum resection in 23–50% of cases. This contributes to maintaining a high interest in the development of intraoperative technologies that allow the differentiation of tumors from surrounding tissues. In this proposed study, we aspire to develop, characterize, and evaluate intranasally delivered tumor-targeting polymeric micelles carrying a self-quenched near-infrared (NIR) imaging agent on its potential in brain imaging and neurosurgical guidance during brain tumor surgery. This system is designed to switch “off” fluorescence signals until the micelles arrive at tumor tissues and begin to release an imaging agent as a monomeric form, resulting in strong fluorescence (“on”) signals on tumor tissues. We believe that the polymeric micelles proposed in this study will offer high sensitivity and specificity in imaging brain tumor for distinguishing tumor tissues from surrounding white matter and ultimately improve surgical outcomes and patient survival, potentially adding decades of quality life.